RCMI Administrative Core

ABSTRACT
The Administrative Core (AC) will provide leadership, oversight, and centralized management of all the
strategic planning, research, dissemination, and implementation activities conducted by the RCMI Cores,
Research Project, Pilot Grants, and administrative support staff. The AC will provide coordination,
communication, and evaluation for all RCMI components, in support of the overarching goals of (1)
significantly enhancing UH’s infrastructure and environment to advance health-equity science in addictions
and cancer prevention research; and (2) increasing underrepresented minority (URM) scientists’ productivity,
discovery, and extramural funding to pursue innovative research and dissemination activities. The long-term
goal of the AC is to provide an infrastructure for the RCMI to leverage health-equity science – in partnership
with community members, organizations, stakeholders, and elected officials – to collaboratively implement a
sustainable data-driven approach for saving lives and preventing infectious and chronic diseases from
disproportionally afflicted vulnerable communities. This goal will be achieved by the successful completion of 5
Specific Aims: Aim 1: Provide strategic leadership for the RCMI – including streamlined administrative
oversight, efficient operational management, clear communication, budget management/oversight, and
synergistic coordination of all components – to maximize a collective impact on health-equity science. Aim 2:
Institute an integrative RCMI Leadership structure that oversees synergistic planning, implementation, and
progress to ensure all aims and milestones are met on time and within budget. Aim 3: Execute an evidence-
based team mentoring program with data-driven career enhancement activities for postdoctoral fellows and
new investigators interested in advancing health-equity science. Aim 4: Advance equitable, collaborative,
synergistic, and sustainable relationships between all RCMI components, URM scientists, community
members, organizations, stakeholders, and elected officials. Aim 5: Develop a centralized program evaluation
system that leverages a clear logic model to inform effective resource allocations and demonstrate an
accelerated RCMI return on investment. The AC will provide the support and infrastructure needed for the
daily management and operations of the RCMI, maintain open lines of communication among all the
associated Cores, Research Project, Pilot Projects, administrative support staff, investigators, and NIMHD
personnel. This AC’s management structure and evaluation plan will ensure that the aims of the RCMI are
successfully achieved.